Proteolysis-targeting chimera against BCL-XL inhibits breast cancer metastasis

Project Summary-Abstract
Metastasis is the major cause of BrCa death. Most women with metastatic BrCa (stage IV) are treated mainly
with systemic therapy such as hormone therapy (for estrogen receptor-positive BrCa), chemotherapy, targeted
therapy, and some combinations. Current treatments are very unlikely to cure metastatic BrCa, with more than
70% death rate within 5 years of diagnosis. Therapeutic targeting BrCa metastasis is largely lacking. Here we
are aiming to develop a single agent with dual targeting capability: 1) to kill metastatic cancer cells directly; 2) to
kill cancer specific regulatory T cells (Tregs) hence inducing anti-cancer immunity. With an effort to search the
potential molecular target, we decided to inhibit BCL-XL using an emerging novel PROTAC technology. With two
lead PROTAC compounds (BCL-XL-Ps) we have recently developed, we found that both compounds can
efficiently lead to the degradation of BCL-XL in vitro and in vivo. Interestingly, it appears that the BCL-XL-Ps work
in all syngeneic cancer models we have tested with the strongest suppressive efficacy in breast cancer
metastasis. Using multidisciplinary techniques, we believe BCL-XL-Ps kill metastatic cancer cells and Tregs
simultaneously as we initially expected. The current project will define the lineage-specific role of BCL-XL in
cancer cells and in Tregs. Even though the direct cancer cell killing may not be sufficient to eradicate metastatic
tumor growth as shown in the preliminary data, a portion of dead cancer cells may provide sufficient auto- or
neo-antigens for T cell activation. In addition, BCL-XL depletion in cancer cells sensitizes them to CD8-T cell
mediated killing. The BCL-XL-Ps-mediated Treg depletion and direct activation of T cells elicits a strong anti-
cancer immunity that can be harvested for cancer therapy. Simultaneous depletion of BCL-XL by BCL-XL-Ps in
cancer cells further sensitize them to CD8-T cell mediated killing. Here we will study the lineage-specific roles of
BCL-XL in cancer. The translational research is also strongly supported by clinical observations that BCL-XL
protein expression predicts shorter patient survival in breast cancer patients. Our long-term goal is to develop
the lead compound into clinic for dual targeting of cancer cells and Tregs in treating metastatic breast cancers.

Public health relevance
Project Narrative The proposed research aims to establish a novel therapeutic target for breast-cancer metastasis by dual targeting cancer cells and immune cells. We propose to use Proteolysis targeting chimera (PROTAC) technology to target pro-survival BCL-XL protein, which leads to the apoptosis of metastatic cancer cells and Tregs. Using in vivo models and fresh cancer specimens, we will determine the mechanisms of targeting BCL-XL in metastatic control and immune regulations.